Neuropathology Core

Core D: Neuropathology Core. Summary/Abstract:
The Neuropathology (NP) Core fulfills several
important roles within the University of Pittsburgh ADRC (PITT-ADRC). Postmortem neuropathological
confirmation of the clinical diagnosis of Alzheimer’s disease (AD) and related disorders and the assessment of
co-existing neurodegenerative and vascular disease processes is essential to promote progress in diagnosis,
treatment and prevention of AD. Since its inception, the NP Core has collected and characterized >739 brains
from PITT-ADRC subjects at various disease stages. This resource has been extensively utilized for teaching
purposes and for research studies by local and national investigators to develop amyloid PET imaging agents
and correlate in vivo amyloid imaging results with postmortem findings, improve our understanding of genetic
factors contributing to AD risk and advance our knowledge regarding the neurobiology of psychiatric
comorbidities and neuroinflammatory processes.
Our proposed approach to fulfill the diagnostic, tissue banking, research and educational roles of the NP
Core is outlined in five specific aims: 1) The NP Core will continue to maintain and expand a well-catalogued
bank of brain tissue samples and fibroblasts of ADRC participants and subjects from affiliated cohorts. A
special emphasis will be placed on harvesting brains from subjects with premortem PiB and tau PET imaging
studies. 2) All banked cases will undergo detailed diagnostic evaluation using the latest consensus criteria and
detailed characterization of comorbid and aging-related pathologies. Results will be shared with ADRC clinical
staff, families and uploaded to local and national databases (NACC). 3) The NP Core will provide
neuropathological skills and expertise to researchers and will expand its efforts to utilize digital microscopy
technologies and image analysis tools for identification and quantification of neurodegenerative pathologies.
The generated pathology endophenotypes will be made available for association studies with genetic
polymorphisms and clinical phenotypes such as the presence of psychiatric comorbidities, a major area of
research at the PITT-ADRC. 4) The NP Core will continue to participate in local and national research efforts
by providing brain bank tissue materials and neuropathology data from diagnostic evaluations. The NP core
will closely collaborate with other PITT-ADRC cores and projects in joint research studies and will engage in
NP Core-driven research projects. 5) In collaboration with the Research Education Component, the NP core
will leverage brain bank materials and expertise to educate neuropathology fellows, residents, medical
students and investigators about the neuropathologic features of neurodegenerative diseases.
Through these aims, the NP core will provide precise diagnostic classifications of ADRC research
participants, enable studies of phenotype variations and broadly support efforts to improve our understanding
of the underlying disease processes.